MOLECULAR MECHANISMS UNDERLYING INTELLECTUAL DISABILITY CAUSED BY MUTATIONS IN THE CHROMATIN MODIFIER KDM5C

PROJECT SUMMARY/ABSTRACT – RESEARCH PROJECT
Mutations in the gene encoding the transcriptional regulator lysine demethylase 5C (KDM5C) are found in
patients with intellectual disability (ID). While the direct link between loss of function mutations in KDM5C and
ID is clear, how KDM5C functions to mediate critical neuronal processes, and therefore the consequence of
mutations for mechanisms of IDD, remains unknown. The goal of this proposal is to understand the
relationship between KDM5C-regulated gene expression programs and the occurrence of ID and additional
comorbid features that are observed in patients. We will achieve this by bringing together a multi-disciplinary
research team with expertise in complementary analytical tools and model systems to test two hypotheses.
Aim 1 tests the hypothesis that the use of human iPSC-derived in vitro cell models of KDM5C-induced ID will
result in the identification of clinically relevant gene expression changes and neuronal functional deficits. One
key model system we will use is iPSC-derived cerebral organoids, which recapitulate structural and molecular
aspects of fetal brain development and are a critical research tool used to define the underlying cause(s) of
neurodevelopmental disorders. Indeed, molecular and cellular studies using in vitro organoid systems allow us
to carry out studies in a human cell context that would simply not be possible in vivo. iPSCs and organoids will
be generated from two sources: (1) Cells from patients with KDM5C-induced ID from a newly recruited cohort
of individuals from which we are generating a genotype-phenotype database; (2) CRISPR-Cas9-mediated
gene editing to generate a KDM5C null allele and a published ID allele (KDM5CA388P) that lacks histone
demethylase activity using existing iPSC lines generated from typically developing controls. We will use this
system to combine morphological, functional and multi-OMICS approaches to define the impact of patient-
associated mutations in KDM5C. Aim 2 tests the hypothesis that the regulation of translation efficiency in
neurons by the fly homolog of KDM5C is conserved in mammalian systems and that this function is important
for cognition. Here we take advantage of fly and mouse animal model systems, both as discovery tools and to
test hypotheses regarding possible contributors to the cognitive effects of mutations in KDM5C. Because other
inherited forms of ID have altered translation and correcting this deficit has shown promise in mouse models of
other ID disorders, we will test whether altered translation similarly plays a key role in a mouse model of
KDM5C-induced ID.
This work is significant because we will define the etiological links between mutations in human KDM5C
and ID. The proposed studies are technologically innovative in the use of complementary model systems and
state-of-the-art genomics techniques such as single cell transcriptomics (scRNA-seq). It is also conceptually
innovative in proposing a role for translation in KDM5C-induced ID.

Public health relevance
PROJECT NARRATIVE Intellectual developmental disabilities (IDD) are frequently diagnosed during early childhood and have dramatic quality of life consequences for the affected individual and their caregiver(s). Significant insight into brain mechanisms of IDDs can be gained by studying single gene mutation IDD conditions such as the one we focus on here, KDM5C, with the use of animal models and human cerebral organoids. In addition to providing critical information regarding the etiology of this cause of IDD, our work has broad implications for other known genetic causes of IDD.